Targeting epigenetic abnormalities to inhibit cutaneous squamous cell carcinoma

Project Summary/Abstract
Chronic ultraviolet (UV) radiation induces not only genetic mutations but also aberrant epigenetic
modifications that affect the expression of transcription factors, oncogenes, and tumor suppressors, leading to
the development of cutaneous squamous cell carcinoma (cSCC), the second most common cancer in the United
States. A better understanding of the mechanisms underlying UV-associated epigenetic abnormalities will
provide novel approaches to inhibit skin malignancies.
Strikingly, chronic UV exposure induces DNA hypermethylation at the promoter of CDKN2A gene, which
encodes tumor suppressors p16INK4A and p14ARF. This epigenetic alteration silences CDKN2A, promoting tumor
growth and metastasis. However, it remains unclear whether the reversal of this epigenetic aberration can
reactivate CDKN2A and inhibit malignant phenotypes of cSCC. In Aim 1, we will use our CRISPR-Cas9-based
epigenome editing tools to specifically demethylate the CDKN2A promoter and investigate the effect of targeted
DNA demethylation on cancer phenotypes.
UV radiation increases the expression of Myc, which is an oncogenic transcription factor. Myc activation is a
cancer hallmark, and the Myc oncogene family is deregulated in many human cancers. When overexpressed,
Myc binds to noncanonical (low-affinity) motifs, invading enhancers, and potentially activates super-enhancers
(noncoding genomic regions defined by unusually high levels of H3K27 acetylation). Cancer-specific super-
enhancers strongly upregulate oncogenes, driving malignancies. However, it remains elusive how aberrant
super-enhancers are formed in cSCC. We hypothesize that overexpressed Myc binds to low-affinity Myc binding
sites, recruits histone acetyltransferase p300, and generates aberrant super-enhancers that drive malignancy.
In Aim 2, we will determine the role of overexpressed Myc in super-enhancer formation in cSCC.
A subset of cSCC displays poor differentiation, which correlates with poor patient survival. However, it remains
unclear what confers the aggressiveness of poorly differentiated cSCC. We hypothesize that small-molecule
inhibitors of DNA methylation and/or Myc suppress poorly differentiated cSCC in vivo by reactivating CDKN2A
and/or inhibiting Myc-associated super-enhancers. In Aim 3, we will use poorly differentiated cSCC patient-
derived xenografts as preclinical models to assess the effects of these inhibitors on tumor growth and metastasis.
Innovative technologies will be used for epigenetic analyses: “PIXUL-ChIP” (high-throughput chromatin
shearing for robust ChIP signals) and “EVA” (epigenetic visualization assay that detects specific DNA
methylation at the single-cell level). With our epigenome editing tools, the proposed study will elucidate the
contribution of epigenetic abnormalities to cSCC aggressiveness and reveal therapeutic potential of modulating
epigenetic marks to suppress cSCC.

Public health relevance
Project Narrative Ultraviolet radiation is the most prevalent carcinogen in humans, leading to the development of skin cancer with over 5 million cases annually in the United States. This environmental factor induces genetic mutations and epigenetic abnormalities that affect the expression of cancer-relevant genes, but it remains unclear how these epigenetic abnormalities drive skin malignancies. Using genome and epigenome editing tools, we aim to elucidate the contribution of epigenetic abnormalities to malignant phenotypes with the goal of developing novel therapeutic strategies to target epigenetic aberrations and inhibit cutaneous squamous cell carcinoma.